Enhancing Breastfeeding Outcomes through Digital Phenotyping

Project Summary/Abstract:
This research proposal responds to the pressing need for comprehensive understanding and targeted support
in breastfeeding outcomes, an area significantly impacting child health and development. Despite the recognized
importance of breastfeeding, existing clinical practices often overlook the intricate interplay of maternal lifestyle
and behavior. Mothers face diverse challenges including return to work, inconsistent milk supply, lack of support,
and postpartum mental stress, all of which profoundly influence breastfeeding success and subsequently, the
well-being of the child. Although national recommendations advocate exclusive breastfeeding for the initial six
months of a child's life, the actual compliance, as reported by the Center for Disease Control and Prevention, is
less than 25%. This study takes a digital phenotyping approach by harnessing passive longitudinal monitoring,
facilitated through smartphones, smartwatches, and ecological momentary assessments (EMAs). By examining
physiological components such as sleep, exercise, and vitals through smartwatches, alongside behavioral
patterns encompassing mobility, screen time, and social support via smartphones, we intend to identify lifestyle
factors during the third trimester impacting breastfeeding outcomes. A pivotal aspect of this research lies in its
ability to bridge the existing knowledge gap by delving into the multifaceted aspects of maternal well-being,
mood, lifestyle, mental health, and social support during the critical period of the third trimester to postpartum.
To our knowledge, this is the first study of its kind to focus on breastfeeding outcomes.
We seek to modify and implement a culturally adapted digital phenotyping protocol tailored for first-time mothers.
Through rigorous data collection, encompassing both the objective data from wearables and mobile devices and
subjective self-reports, we aim to understand the nuanced dynamics affecting breastfeeding success. This
research, anchored in innovative technology and supported by a team with extensive expertise in maternal health
and behavioral science, is poised to transform breastfeeding support. By offering novel insights, our findings will
inform future research endeavors and pave the way for personalized interventions, thereby enhancing
breastfeeding success and ultimately contributing to the improved health and development of children.

Public health relevance
Project Narrative: Despite the National Institute of Health's recommendation for exclusive breastfeeding in the first 6 months for improved child health and development, challenges such as return to work, inconsistent milk supply, and postpartum stress hinder successful breastfeeding outcomes for mothers. Leveraging passive longitudinal monitoring through smartphones and smartwatches, this study aims to explore how physiological and behavioral patterns, along with self-reported factors, in the third trimester impact breastfeeding. The study's approach seeks to transform our understanding of breastfeeding outcomes, paving the way for personalized recommendations, and ultimately improving child health and development.